Diagnostic Failures in Dentistry

Project Summary/Abstract
Despite growing recognition that diagnostic failures are the “new frontier” for patient safety research, there has
been no study to systematically examine diagnostic failures (delayed, wrong or missed diagnoses) in dentistry.
The primary goal of our proposal is to close this knowledge gap by systematically evaluating dental diagnostic
failures (DDFs) associated with periodontal diseases with a goal of moving the profession towards diagnostic
excellence. Periodontal (gum) diseases affect 46% of US adults and may often lead to pain, tooth loss, and/or
poor quality of life when not properly managed.
This work is significant because it is the first attempt to systematically evaluate diagnostic performance
in dentistry. It is innovative because it utilizes a new methodology for mining EHR data to identify diagnostic
errors, and examines the association between diagnostic errors and clinical/health service outcomes. The
approach is grounded in our extensive preliminary work. The investigators are experienced researchers who
have pioneered patient safety research in dentistry and laid the foundation for a diagnostic-centered profession
through developing and disseminating the dental diagnostic terminology SNODDS that enables dentists to
accurately document patients' diagnoses within the EHR in a standardized manner. Our study will be
conducted at two academic institutions, which will provide a robust learning environment.
In Aim 1, we determine the incidence of dental diagnostic failures (DDFs) associated with periodontal
diseases and conditions. This Aim seeks to assess the concordance between clinician-given diagnoses and
established diagnostic criteria from the American Academy of Periodontology (AAP) in order to determine the
baseline incidence of DDFs associated with periodontal diseases. Specifically, we will deploy automated query
scripts to extract critical data elements from the EHR that will be used to generate an EHR-based diagnosis for
comparison with the clinician-given diagnosis. All discordant cases will be reviewed independently by trained
site clinicians and collectively by the expert panel to confirm the presence or absence of a DDF.
In Aim 2 we evaluate clinical and treatment patterns and clinical outcomes following DDFs. In this Aim,
we will examine the patterns of treatment received by patients following their periodontal diagnoses and their
periodontal health outcomes. We hypothesize that patients with inaccurate diagnoses (DDFs) will be more
likely to receive inappropriate treatment (over- or under-treatment) when compared against recommended
treatment guidelines. They will also have poorer clinical outcomes (e.g. progression of periodontal disease,
tooth loss) compared to those with accurate diagnoses (non-DDFs).
We expect that our research will provide the dental profession with a fundamental understanding of
DDFs related to periodontal diseases and conditions. It will also provide a solid roadmap from which to develop
and implement DDF mitigation strategies that will prevent unnecessary harm to dental patients.

Public health relevance
Project Narrative Annually, over 250 million patients receive dental care and yet, little is known about diagnostic failures in dental clinics. Estimates from the medical profession suggest that between 10-15% of patients are misdiagnosed, and there are significant reasons to suggest that diagnostic failures are prevalent in dentistry too. In this study, we seek to identify diagnostic failures, and examine the link between diagnostic failures and clinical outcomes.